FAMILY WELL-BEING RESEARCH NETWORK (“FAM-NET”): Measuring Family Well-Being across the Lifespan

ABSTRACT
Emotional well-being, which includes life satisfaction, life purpose, and positive emotions, is a key public health
target. Although health can influence well-being, only recently has there been increasing attention on how
overall well-being can influence health outcomes. Critical knowledge gaps exist in both understanding the
research on the role of emotional well-being in health and in measuring well-being outcomes, which constrain
valid and rigorous evaluation of intervention strategies. The interdependence of health and well-being within
and among family members has not been well-characterized: the health and well-being of a patient affects
family members, but the well-being of family members--especially informal caregivers or parents--can also
directly affect the well-being of the patient. Moreover, these interrelated effects vary across the lifespan, from
child well-being within a family to elder well-being among family members and relatives.
The specific aims of this U24 research network proposal focus on developing a coordinated set of
collaborative, transdisciplinary mechanisms designed to create, launch, and sustain a new generation of well-
being researchers and innovative research activities across the lifespan, with a special emphasis on measuring
family well-being and child quality of life: (1) improve access to and use of emotional well-being measures by
creating a web-based resource repository of curated instruments, research findings, datasets, and
training/learning materials; (2) stimulate well-being research through funded pilot projects that address the
measurement of well-being across the lifespan with dedicated funding for pediatric quality of life projects; (3)
assemble a research scholars corps with multidisciplinary training and expertise that will support and foster a
pipeline of scholars for future research on measurement. This set of activities will serve to coalesce this
emerging field, building research capacity to support better evaluation of interventions and improving public
health through the measurement of measurement of well-being at the population level.

Public health relevance
NARRATIVE Emotional well-being, which includes life satisfaction, life purpose, and positive emotions, is a key public health target. This proposal will develop a network of transdisciplinary researchers to understand and promote the effects of well-being on health, focusing on interrelated effects of health and well-being at the family level.